Mental health hospitalizations and follow-up care in autistic adults

PROJECT ABSTRACT
Autistic adults experience higher rates of co-occurring mental health conditions than their peers, impacting
quality of life and increasing the complexity and cost of health care. Experiences of adversity, isolation, and
stigma may place autistic people at increased risk for mental health concerns. Mental health services can play
a key role in supporting people to cope with mental health concerns. When mental health is not adequately
addressed, issues frequently escalate to crisis level and treatable mental health conditions become more severe
and disabling over time. While there is no centralized system mental health crisis system in the U.S., emergency
and inpatient hospitalization is an integral part of crisis care for many people. There is limited understanding of
hospitalization in autistic adults, but preliminary findings suggest mental health conditions, including mood
disorders and schizophrenia, are among the most common reasons for inpatient hospitalization in autistic adults.
While hospitals are a common source of emergency and crisis care for mental health, they are often not equipped
to provide quality care. This is a problem amplified in autistic patients because of lack of provider knowledge of
autism, high prevalence of multiple co-occurring conditions, and autism characteristics complicating care
including sensory sensitivity and difficulty with new routines and unknown places. Therefore, care immediately
following hospitalization is an important part of addressing the crisis and working towards maintenance care.
People who do not receive appropriate follow-up care are more likely to cease care and experience hospital
readmissions, service and medication non-compliance, and self-injurious and dangerous behaviors. Because
hospitalization may be particularly traumatic for autistic adults, appropriate follow-up care is vitally important.
Very little is known about mental health care in autistic adults, including hospitalization for and follow-up care
after mental health hospitalization. But the picture of limited provider availability, lack of provider knowledge, and
siloed service systems suggest that care can be vastly improved. The purpose of this study is to examine the
mental health hospitalizations of autistic adults and the care patterns following crisis compared to other adults
hospitalized for mental health conditions. We will do this using two national sources of data: an all-payer hospital
readmissions database and Medicaid claims. Using national all-payer hospitalization data allows a complete
picture of experiences to inform improvement, while focusing on Medicaid claims allows a complete investigation
of patterns and predictors of follow-up care service use and readmission. The ultimate goal is to inform service
delivery system changes that increase care appropriateness and improve quality of life in autistic adults.

Public health relevance
PROJECT NARRATIVE In this project, we propose to use two national sources of data, one all-payer hospital readmission record and national Medicaid claims, to examine mental health hospitalizations (MHH) in autistic adults. We will compare prevalence of all-cause readmission after MHH for autistic and non-autistic adults and examine the patterns and association of follow-up care including outpatient mental health visits within 30 days of discharge, change in psychotropic medications, rehospitalization, and mortality. Understanding what factors lead to MHH and relate to better outcomes following MHH can improve the mental health service system for autistic adults who experience crisis mental health care.